Core B: Analytics Core

ANALYTICS CORE REVISED SUMMARY
The Analytics Core will support all four research components of the TIME-AD program, ensuring coordinated statistical approaches and principled decisions on common challenges. The Analytics Core will (1) work with the Cognition, Exposure, and Covariates Core to ensure construction of analytic data sets is consistent with each proposed study design for each research project; (2) partner with research project leads to develop and implement the analytic strategy for each research project, develop template analysis code for each method, and lead program-wide methodologic decisions; (3) guide investigative teams in each research project on systematic evidence triangulation across study designs; (4) and provide ad hoc guidance on statistical problems that arise in each research project. The TIME-AD program proposes to implement combinations of multiple analyses of AD/ADRD risk factors, relying on different assumptions for causal identification. Methods include doubly robust g-estimation methods using covariate adjustment; instrumental variables analyses drawing on policy or genetic instruments; bias-detecting Mendelian Randomization; and quantitative bias analysis. These approaches will be complemented by methods to quantify the total effect of interventions on each risk factor on population incidence of AD/ADRD and differences in AD/ADRD incidence across populations. Population impact assessments will include population attributable fraction calculations and effect estimate transport methods that allow estimation of total effects in populations with different risk factor profiles. The team includes researchers with expertise in each of these methods. The TIME-AD program uses data from multiple sources, including population-representative cohorts with regularly scheduled measurement waves (Health and Retirement Study, National Longitudinal Study of Youth 1979, Reasons for Geographic and Racial Disparities in Stroke, National Health and Aging Trends Study) and cohorts relying on convenience (UK Biobank, All of US) or membership-based (Kaiser Permanente Northern California) based samples with electronic health record follow-ups. Together these data sets provide excellent statistical power to deliver precise estimates and evaluate effects across all subgroups of Americans (e.g. by age, sex, socioeconomic status, place). The different data sources best support different study designs, and each source entails specific methodologic challenges. The Analytics Core will ensure a unified framework, foster reproducible research and high-quality implementation, and make it feasible to tackle these multiple designs with multiple data sets in each study. The Analytics Core will also work closely with the Maximizing Population Impact Core to ensure analytic decisions reflect the TIME-AD goal of delivering evidence with the best chance to reduce AD/ADRD incidence across all populations and identify drivers of AD/ADRD in populations disproportionately affected by AD/ADRD. The Analytics Core will guarantee integration of the projects and ensure success of the TIME-AD program.